In vivo hematopoietic stem cell genetic modification by viral particles

PROJECT SUMMARY
Hematopoietic stem cell (HSC) gene therapies with lentiviral or CRISPR based gene modification are
demonstrating favorable safety profiles and remarkable efficacy to treat severe monogenic blood disorders with
unmet clinical need, including X-linked Severe Combined Immunodeficiency (X-SCID) and Sickle Cell Disease
(SCD), with feasibility of rapid progress from target discovery and preclinical validation to first-in-human trials.
Despite these successes, the technologies and procedures used in these trials require complex ex vivo bespoke
manufacturing of autologous cell products, are expensive and difficult to scale to treat many patients, and
intrinsically associated with significant risks related to ex vivo manipulation, myeloablative chemotherapy and
bone marrow transplantation. We here propose a novel technology platform based on alpha-retroviral vectors
that shares many of the advantages with the currently dominating delivery platform, lentiviral vectors, but has
increased flexibility to deliver diverse therapeutic payloads, including non-integrating Cas9-based genome
editors, high potential for in vivo gene delivery, and compatibility with scalable production systems. The long-
term goal of our proposal is to further develop this platform for the delivery of gene therapy payloads (integrating
DNA and Cas9/base editor ribonucleoprotein complexes into HSCs in vivo to enable simple, more economical
and widespread application of gene therapies to serve diverse patient populations. A shorter term goal is to
employ the same technology for improved ex vivo delivery of gene therapy payloads to HSCs. Our central
hypothesis is that a single platform based on alpha-retroviral vectors is suitable for ex vivo and in vivo delivery
of genetic therapies with diverse requirements in terms of the type of therapeutic payload and targeting
specificity. In preliminary studies, we have demonstrated that both integrating vectors and non-integrating
genome editors can be delivered into HSC ex vivo and in vivo. Here, we will capitalize on these results and
further expand the reach of these innovative genetic engineering tools with the objectives to: i) develop
integrating vectors to deliver a curative transgene to HSCs in vivo as a modality to treat X-SCID; ii) engineer
virus-like particles for the delivery of Cas9 into quiescent HSC with minimal toxicity both ex vivo and in vivo to
treat SCD; and iii) to modify virus-like particles for the transfer of base editors into HSCs for correction of the
common mutation underlying the bone marrow failure disorder Shwachman-Diamond Syndrome. The alpha-
retroviral based viral particle technology will be used to develop treatments for this exemplary group of diseases
and is also intended to address key general shortcomings of current GT approaches and could be readily
transferable to many other monogenic diseases.

Public health relevance
PROJECT NARRATIVE Gene therapies can definitively treat genetic blood diseases like Sickle Cell Disease, Severe Combined Immunodeficiency (“Bubble Boy Disease”), and Bone Marrow Failure disorders without requiring bone marrow transplant from another individual. However, current gene therapy treatment approaches rely on collection of blood stem cells by a medical procedure from the bone marrow or peripheral blood, then complex manufacture of gene modified blood stem cells outside of the body, and finally transplant of the gene modified blood stem cells back to the patient after first treating the patient with high-dose chemotherapy to allow for blood stem cell replacement. In this proposal, building from our expertise in virus engineering, gene editing, and disease biology, we aim to develop a novel gene therapy approach that could be administered directly to a patient’s blood stem cells by vein, thereby avoiding stem cell collection, complex cell manufacture, and toxic chemotherapy.